Mechano-regulation of circulating extracellular vesicle cargoes to enhance knee joint health

ABSTRACT
Knee osteoarthritis (KOA) represents a major public health burden affecting more than 30 million older
individuals in the United States alone. Standard of care, including rehabilitative programs, is currently limited to
symptom management. To address the lack of disease-modifying interventions for KOA, we herein aim to
provide an integrated view of the complex pathophysiology of KOA as “a disease of the organ”, and
mechanistically investigate how physiological exercise regulates molecular circuitry in cartilage and the
surrounding the knee joint in the setting of KOA. Two inter-related yet independent aims will test the central
hypotheses that mechanotransductive pathways stimulated by exercise promote more youthful molecular
cargoes within circulating extracellular vesicles that promote cartilage integrity directly (Aim 1) and/or
indirectly via alterations in the secreted proteins of the infrapatellar fat pad /synovium complex (Aim 2). We
will accomplish these aims using technically innovative approaches, including (1) an advanced network
medicine framework for multi-tissue multi-omics datasets in order to disentangle the multi-dimensional
contribution of circulating factors on knee joint health at single cell resolution, and (2) a physiologically
relevant model of female aging by which menopause is chemically-induced in middle-aged mice. These
conceptually and technically innovative studies will be carried out by an interdisciplinary team comprising an
exercise physiologist and computational biologist (PI), a stem cell biologist (co-PI), and a bioengineer (co-I).
The breadth of this team enhances feasibility, impact, and the likelihood of success. Successful completion of
the aims as proposed will provide mechanistic insights into how molecular cargo in blood impacts on
osteoarthritic knee joint health in sex- and activity-dependent manner. Ultimately, we anticipate that the studies
proposed will aid in the development of innovative diagnostic and prognostic nano-biomarkers and effective
interventions to the benefit of an aging population.

Public health relevance
PROJECT NARRATIVE While knee osteoarthritis represents a major public health burden affecting more than 30 million older individuals in the United States alone, the standard of care is primarily limited to symptom management. This study will provide an integrated view of the complex pathophysiology of knee osteoarthritis and mechanistically investigate how physiological exercise mitigates knee osteoarthritis according to sex. We anticipate that the studies proposed will aid in the development of innovative diagnostic and prognostic molecular biomarker and effective rehabilitation programs that consider sex-specific variables for the treatment of osteoarthritis.